Altered Diversity of Astrocyte sub-types and Signaling Capabilities in Alzheimer's Disease

Project Summary/Abstract
Alzheimer’s Disease (AD) has been identified as one of the highest priority neurobiological diseases in need of
research advancement, inflicting progressive cognitive impairment on patients, and excessive burden on
caregivers and families. Due to the lack of effective preventative or reparative treatments for AD, it is imperative
to identify cellular or circuit factors contributing to the impairments in learning and memory. It has long been
observed that glial cells are noticeably altered, morphologically and molecularly, under conditions of
neurodegeneration and inflammation, including in AD. Astrocytes in particular have critical roles in synaptic
function, integration of circuit responses, and network homeostasis. It is yet unclear how activity-dependent
dynamics of intracellular signaling in these cells are altered under disease conditions.
Due to the anatomical importance of the dentate gyrus, the heterogeneous signaling characteristics of
hippocampal astrocytes, and the involvement of inflammatory processes in AD, we postulate that: dentate gyrus
astrocytes maintain diverse signaling capabilities in response to distinct neuronal circuit activation, and
that these signals are differentially vulnerable to AD pathology.
Using selective circuit stimulation and membrane-tagged calcium imaging in two distinct populations of
astrocytes of the dentate gyrus, we will investigate the capabilities and susceptibilities of astrocyte responses to
neurotransmission and neuromodulation. Adaptation of calcium datasets to new computational analysis toolsets
specifically designed for the unique characteristics of astrocyte signaling will be used to categorize and profile
capabilities of hilar and molecular layer astrocytes in control animals and in the 5xFAD animal model of AD.
Furthermore, we shall attempt to identify astrocyte sub-populations and alterations in astrocyte diversity within
the dentate gyrus, using single-cell sequencing, cluster analysis, and examination of differentially expressed
genes and pathways. In this way, we will define the susceptible sub-populations of astrocytes in AD, and reveal
alterations in gene expressions in these critically important cells as they undergo pathology-related modifications.
Results from this study will greatly inform on the potential of targeting specific subsets of astrocytes in
development of AD therapies, and will provide a database of transcript levels by which to measure effectiveness
of potential interventions.

Public health relevance
Project Narrative Due to the lack of effective treatments, identification of susceptible cellular and network components in Alzheimer’s Disease (AD) is needed in order to provide fresh insights into the origins and progression of the disease. Using discrete circuit stimulation and calcium imaging in astrocytes in two distinct regions of the dentate gyrus, we will investigate the range of capabilities of astrocyte signaling as well as identify their susceptibilities in the 5xFAD animal model of AD. Furthermore, we will identify the sub-populations and alterations in astrocyte diversity with single-cell sequencing, cluster analysis, and examination of differentially expressed astrocytic genes and pathways that are altered in the dentate gyrus of AD animals.